Metabolomic and Genetic Factors Decoupling Immune Checkpoint Inhibitor Tumor Efficacy and Cardiovascular Toxicity

PROJECT SUMMARY/ABSTRACT
Immune checkpoint inhibitors (ICIs) are an important advancement in oncology and have restored anti-tumor
immune responses, resulting in improved survival in many cancer types. Nevertheless, there is emerging
evidence that ICIs are associated with cardiovascular toxicities, including myocarditis, which has mortality rates
as high as 50% in fulminant cases. Additionally, ICIs are associated with excess atherosclerotic events, such as
myocardial infarction, stroke, and peripheral artery disease. Apart from toxicities associated with ICIs, there is a
small group of patients who are non-responders to ICIs; many recent studies suggest that ICIs may induce
various forms of immune dysregulation, which may paradoxically accelerate cardiovascular disease (CVD).
Immune dysregulation is largely defined by increased oxidative stress, accumulation of reactive oxygen species
(ROS), and immune cell senescence. Senescent immune cells demonstrate limited surveillance of immune
responses, but also become pro-inflammatory due to a permanent change in gene expression profile termed a
senescence-associated secretory phenotype (SASP), that can induce chronic inflammation, tissue damage,
resist immunotherapy, and progress CVD. Based on these observations, we hypothesize that immuno-
senescence is a central linking mechanism of ICI-associated cardiovascular disease (ICI-CVD) and ultimately
length of survival in cancer patients. Importantly, our preliminary work suggests that immuno-senescence that
preexisted prior to treatment, rather than toxicity that developed during treatment, drives cardiovascular risk and
negatively impacts cancer treatment effect. For example, we found that metabolomic measures and epigenetics
prior to ICI treatment predicts the development of cardiovascular events of post-ICI treatment, highlighting the
value of evaluating baseline immune health prior to treatment. In order to address this clinical question, our
project is a paradigm shift by combining clinical data with multi-omics biosample-derived biomarkers before and
after ICI treatment, such as metabolomics, aging through epigenetic markers, and clonal hematopoiesis of
indeterminate potential (CHIP), to develop predictive models that differentiate patients according to their
estimated risk of ICI-CVD and cancer mortality. This systems-level approach utilizes three aims: (1) discouple
the biological predictors of cardiovascular toxicity from ICI efficacy; (2) identify metabolite patterns of human
monocyte-derived macrophages (HMDMs) that are associated with cardiovascular and oncologic outcomes; and
(3) identify genetic and epigenetic determinants, including CHIP, of cardiovascular risk and cancer prognosis in
patients receiving ICI therapy. Using this integrated strategy we aim to address clinical management by providing
biomarkers that predict both subsequent cardiovascular event incidence and poor cancer outcomes. Our findings
may help us determine new therapeutic interventions that separate the anti-tumor benefit of ICI from their
cardiovascular risks. Moreover, we will be able to refine diagnostic criteria, and develop a grading scale for ICI-
CVD that may help improve clinical decision-making in relation to continuing treatment, and ultimately improve
survival, and quality of life for cancer patients receiving immunotherapy.

Public health relevance
Narrative Immune checkpoint inhibitors (ICIs) are powerful cancer treatments that help the immune system fight tumors, but they can also cause serious heart problems like inflammation and clogged arteries. Some patients don’t respond well to ICIs, and research suggests that pre-existing immune aging—where immune cells become worn out and inflamed—may increase both heart risks and cancer progression. Our study aims to identify early warning signs in the blood that can predict which patients are most at risk, so we can make ICI therapy safer and more effective.